Pyridoxal Radical Biocatalysis for the Stereoselective Production of Non-Canonical Amino Acids

Project Summary
Biocatalysis represents a powerful emerging technology for the biomanufacturing of biologically active
molecular agents and clinically significant therapeutics. Previously, the practice of biocatalysis is largely limited
to the utilization and engineering of native enzymology from nature. New-to-nature enzymatic chemistries which
are synthetically useful yet never encountered in biology remain largely underexploited. Combining biocatalysis
and photochemistry, we propose a novel and generalizable photobiocatalysis strategy to reprogram diverse
pyridoxal phosphate (PLP)-dependent enzymes as radical enzymes to catalyze stereoselective intermolecular
radical reactions. Notably, these newly developed enzymatic reactions are not previously known in either
biochemistry or organic chemistry. By merging photoredox catalysis powered by visible light and pyridoxal
biocatalysis fine-tuned by directed evolution, a range of non-canonical amino acids that are often incorporated
into medicines and therapeutic protein targets will be produced with excellent stereocontrol. By leveraging novel
activation mechanisms involving open-shell PLP covalent intermediates, we will design and develop
stereoselective biocatalytic radical C–C bond forming reactions at the a, b, or g position of abundant amino acid
building blocks, furnishing an array of not easily accessible non-canonical amino acids, including those
possessing a well-defined stereochemical dyad or triad which have remained out of the reach of traditional
chemical and biological synthesis. Radical pyridoxal biocatalysis eliminates the need of tedious protecting group
manipulation often required by traditional chemical synthesis, providing a modular, convergent and highly
stereoselective approach to manufacturing biomedically valuable non-canonical amino acids.

Public health relevance
Project Narrative Non-canonical amino acids are essential building blocks in bioactive natural products, clinically significant peptide therapeutics, and biomedically important proteins. By advancing radical pyridoxal biocatalysis which is both new-to-biology and new-to-chemistry, we will develop new methods for the stereoselective bioproduction of valuable non-canonical amino acids. The new photobiocatalysis platform will provide a powerful toolbox for the assembly of small- and macromolecules with biomedical significance, leading to a substantially positive impact on public health.